Role of Skeletal Muscle Lymphatics in Duchenne Muscular Dystrophy Regulation

Duchenne muscular dystrophy (DMD) is an incurable, X chromosome-linked muscle disease that exhibits
skeletal muscle wasting/weakness and the associated inflammation and dysfunction. Though available data on
anti-inflammatory drugs in DMD patients and animal models are promising in diminishing inflammation and
promoting muscle healing in patients, further understanding the inflammatory mechanisms and DMD
pathogenesis is critical to develop the next generation of DMD drugs. The lymphatics have emerged as a central
player in the process of inflammation and play active roles in both the resolution and progression of inflammation.
This proposal brings a novel perspective for treatment of DMD. Since the lymphatic system plays active roles in
both the resolution and progression of inflammation, the idea is that further increasing lymphangiogenesis in
muscle tissues will augment lymph transport, and consequently, lessen inflammation and improve muscle health
in DMD muscle. Preliminary data demonstrate: i) lymph transport in the distal pelvic limb is decreased while
lymphatic vessel density is increased in tibialis anterior muscle from the severely affected, D2mdx mice; ii)
skeletal muscle-specific overexpression of vascular endothelial growth factor (VEGF)-D increases
lymphangiogenesis in normal muscle, with an increase in muscle weight and a positive trend in improving
forelimb grip strength and iii) augments lymph transport in denervated muscle. Hence, central hypotheses
are: 1) Inflammatory lymphangiogenesis combined with a decrease in lymphatic contractile activity cause a
decrease in lymph transport, thereby causing chronic inflammatory status in muscles of DMD animals and 2)
further augmenting lymphangiogenesis with VEGF-D overexpression beyond the level of inflammatory
lymphangiogenesis observed in dystrophic muscle will improve lymph transport in skeletal muscle, and
consequently, resolve the inflammation and attenuate muscle weakness and dysfunction in DMD animals.
Specific Aims are: 1) To determine the changes in lymphatic structure and function in skeletal muscle of DMD
mouse and canine models and 2) To determine whether experimentally increasing lymphangiogenesis in skeletal
muscle improves muscle health in D2.mdx mice and golden retriever muscular dystrophy (GRMD) dogs. Different
age groups of D2.mdx mice and wildtype control DBA/2J mice will be used. GRMD dogs and muscle biopsy
collections from muscle dystrophy patients of various dog breeds will also be used. Overexpression of VEGF-D
in D2.mdx mice and in GRMD will be achieved by genetic or adeno-associated virus approaches.
Lymphangiogenesis, inflammation, lymphatic contractility and lymph transport, muscle health and function will
be evaluated in controls and experimental animals. This proposal will provide novel information regarding the
therapeutic role of lymphangiogenesis in improving muscle health in DMD animal models.

Public health relevance
Duchenne muscular dystrophy (DMD) is an incurable, muscle disease that affects 1 in 3500-6000 boys world- wide. Since the lymphatic system plays active roles in both the resolution and progression of inflammation, our idea is that further increasing the lymphatic vessel density in muscle tissues will augment lymph transport, and consequently, lessen inflammation and improve muscle health in DMD muscle. In this study, we will use mouse and dog models of DMD to understand how new lymphatic capillaries and the improved contractile function of lymphatics will help skeletal muscle fibers to reduce inflammation and improve muscle strength and health in DMD animals, which would potentially provide therapies to improve health in patients with DMD.